Mechanistic bases for the exaggerated mechanoreflex in peripheral arterial disease

PROJECT SUMMARY Peripheral artery disease (PAD) is a common vascular disease that currently affects >10 million people in the U.S. and >200 million people worldwide. PAD prevalence and incidence are sharply age-related and with our national population ever aging, we will see a huge rise of PAD diagnoses. PAD refers to atherosclerotic occlusion of vessels supplying lower extremities creating an ischemic environment during exercise. The ischemic environment causes intermittent pain (i.e., claudication) and exercise intolerance. Along with pain, these patients experience exaggerated increases in blood pressure which increase their risk of suffering an adverse ischemic event in the form of cardiac fibrillation and/or stroke. Patients are frequently advised to avoid strenuous physical activity, however, a marked increase in blood pressure occurs during even low intensity walking exercise. The exercise pressor reflex, a feedback neural control mechanism activated by the mechanical and metabolic signals associated with skeletal muscle contraction, contributes importantly to autonomic and cardiovascular adjustments during exercise. This reflex is exaggerated in PAD and multiple lines of evidence indicate that the mechanical portion of the reflex (i.e., the mechanoreflex) specifically underlies that exaggeration. Thus, the mechanoreflex contributes to exaggerated increases in blood pressure and exercise intolerance in PAD patients. The overall goal of the experiments proposed is to uncover the mechanisms of mechanoreflex exaggeration in PAD. I plan to use the decerebrate, unanaesthetized rat model of simulated PAD in which a femoral artery is ligated for ~72 hours. To isolate the mechanical from the metabolic signals associated with skeletal muscle contraction, I use a 30 s dynamic passive hindlimb skeletal muscle stretch protocol which mimics the exaggerated mechanoreflex in PAD patients. My preliminary data indicates that the thromboxane A2 receptors (TxA2-R) located on the sensory endings of skeletal muscle afferents plays a role in the exaggerated mechanoreflex. TxA2-R are Gq-protein coupled receptors that signal the formation of inositol triphosphate 3 (IP3) which plays a major role in intracellular signaling. While this second messenger pathway is well defined in isolated neurons and in the chronic pain response seen in rodent models of pain, it has not been investigated in our field of blood pressure regulation during exercise. My aim is to target IP3 receptors within skeletal muscle sensory neurons to determine the role of second messenger signaling in the exaggerated blood pressure response during mechanoreflex activation in a rat model of PAD. The proposed experiments will enhance our understanding of second messenger signaling within sensory neurons that will provide the foundation for the future development of specific therapeutic targets to improve cardiovascular and autonomic function during physical activity and exercise in PAD patients.

Public health relevance
PROJECT NARRATIVE Exaggerated increases in blood pressure and exercise intolerance are common occurrences in the >10 million people in the U.S. currently diagnosed with peripheral artery disease (PAD). These occurrences increase a PAD patient’s risk of cardiovascular morbidity and mortality and reduce quality of life. The proposed experiments will investigate the contribution of second messenger signaling within skeletal muscle sensory neurons to the exaggerated blood pressure response during exercise and may provide the foundation for development of therapeutic targets designed to improve blood pressure regulation in PAD patients.